Core 03: Community Engagement and Outreach Core

Project Summary: Community Engagement and Outreach Core
Community Engagement and Outreach (CEO) is a Core of the Louisiana Clinical and Translational Science
Center (LA CaTS) that facilitates meaningful community involvement in LA CaTS research at all levels.
Expanded use of community-based participatory research (CBPR) has been noted as a “strategic imperative” to
develop effective interventions to address health disparities. Community Engagement is an essential component
of the research process. A review of the history of earlier population-based studies, in both majority and minority
populations, indicates that requisite to a study's success is the comprehensive involvement of the study
population's Community. Over the past nine years, CEO has successfully forged and nourished relationships
with various community members some of whom serve on the three active Community Advisory Boards in New
Orleans, Baton Rouge, and Shreveport. Additionally, the CEO has provided web-based and in-person training
to LA CaTS researchers, CAB members, and community organizations on core principles of CBPR, health
disparities and social determinants of health, and their application to clinical and translational research. With
community-partnership and -input, LA CaTS investigators increased their success in research funding.
Additionally, the investigators have been responsive to community-identified health concerns and are aligning
those concerns with their research focus. To actively foster academic-community collaborative research, CEO
established and has maintained the LA CaTS Community Scholars Program (LaCoSP). Building on the
foundation laid for the next funding cycle, the specific aims of the CEO fall into three categories: 1) Expand the
reach of LA CaTS into Louisiana communities, allowing greater community involvement in setting research
priorities, identifying health priorities of communities, and creating more opportunities for academic-community-
Health systems research partnerships in Louisiana; 2) Provide services and resources to LA CaTS investigators
and community partners to facilitate bi-directional and trusted community engagement and outreach activities,
community-engaged research, and effective translation of research findings; and 3) Create and maintain
strategic partnerships between researchers, healthcare practitioners, and lay communities that will promote
community-engaged translational/clinical research and health promotion leading to mitigation of health
disparities.